VAREC Administrative Core

Administrative Core Abstract
The administrative core serves as the central organizing entity for the four research projects, research core
and dissemination core. Its primary goal is to facilitate the conduct and dissemination of research of the
Vanderbilt AUD Research and Education Center (VAREC). The administrative core will organize monthly
steering committee meetings of the project and core PIs to chart the course of VAREC. It will coordinate
communication between VAREC and an internal advisory board, as well as a Program Advisory Committee. It
will oversee budgets and yearly progress reports for the center. The Administrative core will chart the future
scientific course of the center, in consultation with the steering committee and Program Advisory Committee.
These activities of the Administrative Core will be led by Dr. Winder, in consultation with Associate Director Dr.
Blackford.